LEADER Summer Undergraduate Research Experience Program

PROJECT SUMMARY/ABSTRACT
The overall goal of the LEADER Summer Undergraduate Research Program (LSURP) is to increase the diversity
of talent in the applicant pool for graduate programs in the environmental health and biomedical sciences both
at the University of Texas at Austin (UT Austin) and our peer institutions. Research has unequivocally shown that
an inclusive and diverse workforce substantially advances scientific discoveries and that groups of
heterogeneous perspectives and backgrounds outperform homogeneous groups in problem-solving and making
more significant contributions to scientific impact. However, data indicates an underrepresentation of different
populations pursuing graduate studies in biomedical and environmental health sciences, which does not reflect
the current and growing demographics in the US. Compounding this problem, the most competitive graduate
applicants at The UT Austin College of Pharmacy (UT COP) have prior research experience and familiarity with
biomedical and environmental health sciences. Furthermore, candidates who can demonstrate resilience and
grit in character when facing challenges are sought out due to the nature of graduate training and the scientific
process. With this understanding, the LSURP aims to provide an immersive summer research experience for its
participants from Texas' Historically Black Colleges and Universities and Hispanic Serving Institutions (HBCUs
& HSIs) and broad exposure to environmental health and biomedical sciences careers. Finally, this program
provides training in best practices for graduate school applications, focusing on developing a personal statement
that clearly describes the student's background, attributes, and familiarity with environmental health sciences
careers. Recruiting and training the next generation of the environmental health sciences workforce, particularly
enhancing the workforce's pipeline and diversity, is in direct alignment with theme three: "Enhancing EHS Through
Stewardship and Support" of the NIEHS strategic plan.

Public health relevance
PROJECT NARRATIVE The LEADER Summer Undergraduate Research Program (LSURP) aims to diversify graduate program applicants in environmental health and biomedical sciences. LSURP offers a comprehensive summer research experience and career development for participants from Texas' Historically Black Colleges and Universities and Hispanic Serving Institutions. This initiative aligns with theme three of the NIEHS strategic plan by enhancing the diversity of the environmental health sciences workforce pipeline.